Expanding Safe Water Access to Improve Health Outcomes in Appalachia: The Rural Water Filtration and Health (RWELL) Trial

PROJECT SUMMARY
Consumption of unsafe drinking water is associated with a substantial burden of disease. For children <5 years
old, unsafe drinking water is one of the leading risk factors for enteric pathogen infection and diarrhea incidence.
Violations of health-based regulations in public drinking water systems are highest in lower-income rural areas
of the United States (US) overall, and particularly in the Central Appalachia region. Appalachia is also impacted
by substantial disparities in health outcomes, including higher mortality rates for 7 of the 10 leading causes of
death. Estimates indicate ~40 million people in the US live in homes with unregulated private wells. However,
our understanding of drinking water contaminants and associated health impacts for individuals living in house-
holds with private water supply in rural areas of the US is severely limited by a lack of data – particularly for
individuals living in low-income households in rural areas of Appalachia, and Central Appalachia especially. Our
preliminary studies in Central Appalachia indicate that many lower-income households with private wells or
spring water have relatively higher exposures to waterborne pathogens (and some chemical contaminants). Our
overarching goal is to assess the potential of a low-cost, household-level, water treatment intervention for ex-
panding safe water access and improving health outcomes and wellbeing for rural households without utility-
supplied water. We propose to enroll 480 lower-income households (~1,584 individuals) with well or spring water
and conduct a cluster-randomized controlled trial in 10 Central Appalachia counties (in VA and TN) to evaluate
the hypothesized benefits of point-of-use water treatment using countertop water filters. We will build on estab-
lished relationships with a range of state and local agencies for recruitment, and will address the following aims:
1) Measure the effect of drinking water filtration on the incidence of acute gastrointestinal illness among infants,
children, and adults; 2) Measure the effect of drinking water filtration on the presence and quantity of bacterial,
protozoal, and viral waterborne pathogens detected in saliva and stool biospecimens; and 3) Quantify fecal
indicator organisms, waterborne pathogens, and regulated chemical contaminants in drinking water samples
from treatment and control households. This will be the first randomized controlled trial in the US to evaluate
point-of-use water filtration for households with well water. This effort is designed to rigorously assess and quan-
tify the benefits of a relatively low-cost and easy to use water treatment approach that can also improve the taste
of water, and is a less-costly alternative to bottled water reliance. Findings from this study will also substantially
improve our understanding of which waterborne and enteric pathogens infants, children, and adults living in
households with private water supplies in rural areas are exposed to and infected with, enabling more informed
estimates of the associated burden of disease for rural populations without utility-supplied water. Such results
will help to increase awareness of the need for improved policies and programs to expand access to safe drinking
water for vulnerable and underserved populations in rural Appalachia and other rural areas of the US and beyond.

Public health relevance
PROJECT NARRATIVE Pathogens and contaminants in drinking water are known to cause or contribute to negative health outcomes. However, for many rural and lower-income populations in the United States, and in rural regions of Appalachia in particular, we know relatively little about exposures to unsafe drinking water or the associated impacts on health and wellbeing. This study will rigorously evaluate how the use of drinking water filters may improve health outcomes for people living in lower-income rural households without utility-supplied water in Central Appalachia.